Mouse model of neonatal fungal colonization to study homeostasis and disease

SUMMARY
While the fungus Candida albicans has largely been studied as a pathogen, its primary lifestyle is as a
commensal on mucosal surfaces, including the oral cavity. Microorganisms that occupy mucosal surfaces are
critical for appropriately tuning immune responses to ensure efficient responses to invading pathogens while
limiting responses directed towards host tissues. In this context, commensal fungi play important roles in host
immunity and inflammation. For instance, C. albicans colonization induces cross-reactive T cells and innate
memory in immune cells, a mechanism termed trained immunity. Accumulating evidence from our group and
others have convincingly demonstrated that oral commensal colonization with C. albicans induces specific
immune responses, therefore contributing to mucosal immune system plasticity. However, our knowledge of
antifungal immunity is based on data of adult animals. Importantly, humans are colonized with C. albicans during
birth. Furthermore, the neonatal immune system has long been regarded immature when compared to the adult
immune system. However, is becomes clear that neonatal immunity is specifically adapted to prevent pathogen
invasion, while supported its development. However, the fundamental immunological consequences of
C. albicans colonization in neonates are still unknown. We developed a novel mouse model of commensal
Candida colonization in neonates. This proposal will characterize oral mucosal immune cell populations in
neonates in response to commensal Candida colonization (Aim 1) and elucidate age related differences in IL-
17 and IL-22 immunity during oral fungal colonization (Aim 2).

Public health relevance
NARRATIVE The fungal organism Candida albicans can cause localized mucosal disease or life threatening invasive candidiasis. These diseases afflict individuals on chemotherapy, transplant patients taking immunosuppressive drugs, asthma patients using inhaled corticosteroid drugs or others with compromised immune function such as infants. The objective of this project is to understand how the neonatal immune system established homeostasis and prevents fungal tissue invasion during colonization.